Targeting Lymphoma: A Multimodal Approach using Radiation, CART-19 Therapy, and Gut Microbiome Modulation

Our previous groundbreaking research, published in 2020 and 2023, unveiled the remarkable synergy achieved
by combining oral Vancomycin with radiation therapy (RT) or Chimeric Antigen Receptor T-cell therapy (CART)
in enhancing the antitumor response. This innovative approach exploited Vancomycin's unique ability to
selectively deplete specific gut microbiota while promoting the cross-presentation of tumor-associated antigens
(TAAs) by dendritic cells (DCs) post-therapy. Notably, our preclinical studies demonstrated significant
improvements in antitumor effects across multiple mouse models, including metastatic melanoma, lung cancer,
and lymphoma. Building upon these groundbreaking findings, we embarked on a pioneering randomized pilot
study in stage I NSCLC patients, which yielded compelling results, including extended Progression-Free Survival
(PFS) and Overall Survival (OS) when Vancomycin was integrated with RT. Subsequent investigations further
illuminated Vancomycin's profound impact on bacterial populations, along with notable alterations in gene
expression related to TAA cross-presentation and reductions in short-chain fatty acid (SCFA) concentration in
the stool. Our proposed research represents a significant advancement in cancer treatment strategies as we
seek to optimize the combination therapy of RT, CART, and gut microbiome modulation for maximal antitumor
effects. This novel approach involves a meticulous exploration of optimal RT parameters, including dose,
fractionation, and treatment volume, in tandem with CART therapy. Moreover, we aim to unravel the intricate
mechanisms underlying Vancomycin-mediated gut microbiome modulation and its role in augmenting the
antitumor effects of the combination therapy. To validate the transformative potential of our findings, we are
poised to conduct the first controlled clinical trial of antimicrobial/RT/CART combination in lymphoma patients.
This landmark trial, comprising two arms—RT alone plus CART and RT plus Vancomycin plus CART—will serve
as a pivotal step towards revolutionizing cancer treatment paradigms. The comprehensive evaluation will
encompass feasibility, toxicity, CART expansion as primary endpoints, alongside secondary endpoints such as
PFS, OS, gut microbiome signature, SCFA levels in the stool, and molecular characterization. In summary, our
research endeavors to push the boundaries of cancer therapy by harnessing the synergistic benefits of RT,
CART, and gut microbiome modulation. By pioneering this innovative treatment approach, we aim to redefine
the landscape of cancer treatment, offering newfound hope to patients and paving the way for transformative
advancements in oncology.

Public health relevance
Our groundbreaking research, published in 2020 and 2023, revealed the remarkable synergy of combining oral Vancomycin with radiation therapy (RT) or Chimeric Antigen Receptor T-cell therapy (CART) to enhance the antitumor response. Now, our proposed research aims to push the boundaries of cancer treatment further by exploring a novel approach that combines RT, CART, and gut microbiome modulation. This triple combination therapy holds promise for cancer treatment, offering new avenues for more effective therapy.